Enhance Immunoprevention by Blocking Early Expansion of Suppressive Myeloid Cells - Supplement Proposal

PROJECT SUMMARY Immune checkpoint blockade has proven an effective treatment for a subset of head and neck cancer (HNC) patients. However, over 85% of the patients cannot benefit from this strategy, largely due to the highly immunosuppressive tumor microenvironment (TME) in established cancers. Oral leukoplakias / Oral Epithelial Dysplasias (OEDs) precede HNC and offer a unique time window for disease eradication. However, surgical resection in the orofacial region results in significant morbidity and function loss, and more importantly, cannot reverse field cancerization. A subset of OEDs transform into malignancy despite vigilant follow-ups. Frequent immune cell infiltration is a common feature of OEDs, however, little is known about when and how OEDs evade from immuno-surveillance and reach a point-of-no-return. Through the support of the parent award, we constructed unique genetically engineered mouse models, which can model a spectrum of OED/HNC lesions with high-fidelity histologic and immunophenotypic resemblance to human diseases. In this supplement, two immunoprevention teams within the Immuno-Oncology Translational Network will integrate a recently developed immune profiling analytical pipeline for single-cell RNA-Seq data sets to assess the prevention effects of a novel combination, which aims to mitigate the early expansion of suppressive myeloid cells and to enrich effector CD4+ T-cells. The new technologies developed through the supplement will strengthen the two parent projects and inform new promising immunoprevention assets for genetically high-risk OEDs.

Public health relevance
PUBLIC HEALTH RELEVANCE Oral leukoplakia and oral erythroplakia are among the most common potentially malignant mucosal disorders that exhibit epithelial dysplasia and immune cell infiltration. However, it remains unclear which subset of these pre-malignant lesions can effectively evade from host immuno-surveillance and constitute a bona fide high-risk group. This translational program will characterize the genomic and immunologic profiles of high-risk pre-malignant mucosal lesions and qualify our potent lead compound as a priming agent to metabolically enhance immunoprevention regimens, mitigating the transformation of oral pre-malignancies.